Applying Relational Coordination to Implement a Pulmonary E-consult Intervention

Introduction: This is the second submission of a VA HSR&D CDA proposal for Seppo Rinne, MD PhD. Dr.
Rinne is a practicing VA Pulmonologist, Clinical Informaticist, and a Core Investigator in the HSR&D Center for
Healthcare Organization and Implementation Research (CHOIR). This proposal incorporates extensive
revisions to address prior reviewer comments, which has led to a refined research focus and a rigorous career
development plan. Since the first CDA submission, Dr. Rinne transferred to a new VA research environment
that is closely aligned with his career goals, updated his mentoring and advising team to support these new
goals, and established strong working relationships with key operational partners. The current proposal builds
on Dr. Rinne’s previous training experiences and preliminary research to improve multidisciplinary coordination
of pulmonary care by developing and implementing a theoretically-based informatics intervention.
Background: Access to specialty care is often insufficient to meet demand. To improve timeliness and
efficiency of specialty care, VA implemented electronic consultations (e-consults), which allow asynchronous
provider-provider coordination through the electronic health record. However, limited research has considered
potential unintended consequences of e-consults on patients’ and providers’ relationships and their quality of
communication. Relational Coordination (RC) Theory provides insight that can address these gaps in
knowledge and inform the design and implementation of e-consult interventions.
Objective: To combine RC Theory with an established implementation model to guide the following Aims:
Aim 1: Explore patient, PCP, and pulmonologist perspectives of e-consults and relationships.
Aim 2: Develop consensus on essential components of pulmonary e-consult communication.
Aim 3: Design and implement a pulmonary E-consult-First intervention.
Methods: Aim 1 will use semi-structured interviews to explore perspectives on how e-consults impact
interpersonal relationships and how patients and providers develop high quality relationships in the context of
frequent e-consult use. Aim 2 will use a multi-step process with Delphi panels and Veteran focus groups to
develop consensus on essential components of pulmonary e-consult communication. Aim 3 will: (A) apply a
novel implementation strategy using social network analysis to identify influential individuals who can act as
change agents; (B) work with these individuals and other local stakeholders to adapt information from Aims 1
and 2 to develop an e-consult intervention; and (C) evaluate the effect of the intervention and implementation
strategy by conducting interviews to assess implementation outcomes, interrupted time-series analysis to
examine wait times, and patient and provider surveys on satisfaction and the quality of coordination.
Expected results: The proposed research will identify evidence-based practices to build and maintain patient
and provider relationships that support e-consult use and establish new communication norms. These findings
will inform the design and implementation of a successful e-consult intervention grounded in RC Theory that
will be highly transferrable and adaptable to local contexts.
Conclusions: Informatics interventions that consider humanistic elements of relationships and communication
will lead to better healthcare delivery. Research on pulmonary e-consults will act as a model to improve quality
and efficiency across specialty care. Therefore, the research outlined in this proposal is highly relevant to VA
priorities of improving the timeliness of care, modernizing systems, and focusing resources more efficiently. Dr.
Rinne is supported by a robust mentoring team, strong operational partners, and an outstanding research
environment. The research and training objective described in this CDA proposal will provide him with the
necessary knowledge and skills to become a successful and independent VA investigator focused on
improving multidisciplinary coordination through novel, informatics-based interventions.

Public health relevance
Patients with respiratory disease are frequently referred for pulmonary consultation, but access to pulmonologists is often insufficient to meet demand. To address this challenge, the VA uses “e-consults” which allow primary care providers to get rapid advice from pulmonologists through the electronic health record. This approach to coordinating patient care can improve timeliness and efficiency, though there are also concerns that it could adversely affect patient and provider relationships and the quality of communication. In the proposed research, I will explore these potential unintended consequences and identify best practices to support high quality e-consult coordination. I will use this information to design, implement, and test an E- consult First intervention, in which all pulmonary consult requests are first entered as e-consults. I will assess the impact of the intervention on diverse outcome measures. This research has the potential to improve the quality of e-consult coordination, which could lead to systems that offer more timely specialty care.